Macrophage-specific IEX-1 – A Novel Mechanism in the Pathogenesis of Atherosclerosis

Macrophage-specific IEX-1 – A Novel Mechanism in the Pathogenesis of Atherosclerosis
Atherosclerosis is a chronic inflammatory disease characterized by the accumulation of lipids in the artery wall.
It is the leading cause of morbidity and mortality in the US. Several immune cells are involved in genesis of
atherosclerosis; however, macrophages play a central role in all stages of the disease. Emerging evidence
suggests that both the quantity and phenotype of macrophages influence the inception and progression of
atherosclerotic lesions. Several macrophages subsets have been identified in atherosclerotic plaques,
including classically-activated (CAMs), alternatively-activated (AAMs), and Mox based on their distinct gene
expression. Macrophages with CAMs-like characteristics play a crucial role in initiation of atherosclerosis by
infiltrating in sub-endothelial space and promoting inflammation. They engulf lipids and become foam cell to
form plaque. In contrast, AAMs-like macrophages are enriched in regressing plaques. They inhibit
inflammation and exhibit reduced foam cell formation. However, the identity of bona fide factors that critically
regulate macrophage phenotype remain poorly understood. As a result, there is a dearth of the effective
strategies to inhibit pro-atherogenic phenotype of macrophages to reduce atherosclerosis. IEX-1 is a stress-
inducible gene that is highly expressed in macrophages. Our preliminary investigation revealed that IEX-1 is
essential for atherosclerosis development and that its deficiency protected mice against atherosclerosis without
impacting cholesterol metabolism. Interestingly, IEX-1 deficiency reversed the phenotype of macrophages
infiltrated in aorta from CAMs to a AAMs-like state, with only little effect on macrophage infiltration. AAMs-
biased polarization preceded the development of atherosclerotic plaque. In the current proposal we will
address the hypothesis that IEX-1 activity in macrophages is required for atherogenesis. To address this, we
propose to use a novel mouse model in which IEX-1 will be selectively deleted from macrophages on ApoE-
deficiency background. We will study its impact on atherosclerotic plaque formation, aortic macrophage
phenotype, and inflammatory status. Furthermore, to gain a mechanistic insight into how IEX-1 contributes to
atherosclerosis, we plan to investigate a role of apoptosis and glycolysis in macrophage polarization and foam
cell formation, the central step in plaque formation. We will employ several pharmacological approaches to
alter IEX-1 expression or glycolysis and evaluate its impact on macrophage phenotype and foam cell
production. Together, these studies will advance our understanding of how macrophage phenotype regulates
atherosclerosis. The results may help develop promising therapeutic or diagnostic approaches for lipid-driven
inflammatory conditions such as atherosclerosis, diabetes, and obesity.

Public health relevance
Project Narrative: Atherosclerosis is a chronic inflammatory disease of large blood vessels and is the primary cause of ischemic heart diseases and strokes. Current understanding of the molecular pathways involved is limited and thus obscures effective treatment options. Our data highlight a previously unknown, but crucial role, of IEX-1 in development of atherosclerosis. Thus, targeting IEX-1 or pathways activated by IEX-1, may help develop novel therapies for this highly prevalent disorder.